Midwest Biomedical Accelerator Consortium: MBArC

Project Summary/Abstract
The ultimate goal of biomedical research is to create new devices, drugs, and technologies that
prevent, diagnose, and treat human diseases. Like scientific discovery, biomedical technology
commercialization is complex and requires mentorship, resources, collaboration, and risk.
However, several hurdles limit commercialization of promising laboratory discoveries, including
1) lack of awareness by academicians that commercialization is an option, 2) concerns that
commercialization efforts delay academic advancement, and 3) failure to connect investigators
with the collaborators and experts necessary to complete the commercialization process. The
objective of this Research Evaluation and Commercialization Hub (REACH) proposal is to
establish a partnership between the University of Missouri-Columbia (MU) and the University of
Kansas Medical Center (KUMC) that will promote academic entrepreneurship and
commercialization. To this collaboration MU brings its outstanding biomedical and bioengineering
research programs and its vibrant track record of participation in the Coulter Translational
Research Partnership Award program. KUMC provides its exceptional biomedical research
programs and Frontiers, its NIH Clinical and Translational Science Award (CTSA). In addition,
each institution has existing partnerships that strengthen and extend the alliance - i.e. 1) MU with
University of Missouri state system universities in Kansas City, St. Louis, and Rolla; and 2) KUMC
with the Kansas Idea Network of Biomedical Research Excellence (K-INBRE) and the Sustainable
Heartland Accelerator Regional Partnership Hub (SHARPhub). The leadership team of this
network, entitled the Midwest Biomedical Accelerator Consortium (MBArC), will employ the
following strategies to increase biomedical research commercialization: 1) leverage MBArC’s
geographic and institutional scope to develop strategic partnerships that invite scientists to
engage in technology transfer and commercialization, 2) give academicians the training and
resources needed to validate the clinical and commercial feasibility of their innovations, 3) provide
researchers with funding and mentorship to complete product definition studies and attract follow-
on funding, and 4) offer experiential learning opportunities in biomedical innovation and
entrepreneurship. This initiative will build on existing programs in outstanding institutions to
increase health-related business development, including small businesses, in Missouri, Kansas,
and adjoining states. The MBArC REACH Hub will promote commercialization of novel scientific
discoveries and establish a sustainable infrastructure to translate scientific discoveries into
commercial products that prevent and treat high-burden diseases afflicting the US population.

Public health relevance
Project Narrative In many cases, scientific discoveries in biological research laboratories can only improve the health of citizens if the scientists who made the discoveries work with financial, business, and legal experts to create businesses that manufacture and sell health-related products. However, the lengthy process of creating a health-related small business often is not completed, even though the discovery was important and could have been converted into a successful business product. The objective of this project is to establish a multi-university working group, entitled the Midwest Biomedical Accelerator Consortium (MBArC), whose goal is to recruit scientific teams with important biological discoveries, train them in business development methods, and create new small businesses capable of manufacturing and selling health-related products.